MORPHOLOGIC FEATURES OF HYPERTROPHIC CARDIOMYOPATHY

The morphologic features of 220 patients with hypertrophic cardiomyopathy (HC) were described. The major gross morphologic features of HC, in order of decreasing frequency, are as follows: 1 ) dilated atria (100%); 2) increased heart weight (95%); 3) nondilated left ventricle (79%); 4) thickened mitral valve (75%); 5) fibrous endocardial mural plaque, left ventricular outflow tract (72%); and 6) a ventricular septum thicker than the left ventricular free wall (60%). Gross left ventricular fibrosis occurred in 84% of the patients and rarely was a consequence of associated narrowing of an epicardial coronary artery disease. HC may cause death in any decade of life. The diagnosis of HC in the very young (age <10 years) and in the very old (age >70) is more difficult clinically and at necropsy than in the intermediate age groups. Patients with the obstructive type of HC usually have larger hearts, a higher frequency of a fibrous plaque in the left ventricular outflow tract, and a higher frequency of a thickened mitral valve than those without obstruction. Left ventricular cavity dilation is present in about 20% of patients with HC and is a result of either operation (with survival >43 months) or extensive left ventricular wall scarring.